dkNET Coordinating Unit: Harnessing the Power of AI and Data Science forCollaborative Discovery and Sharing in the DK Community

PROJECT SUMMARY
As the NIDDK Information Network (dkNET) Coordinating Unit we must develop strategies to ensure that dkNET
continuously evolves to meet community needs. As the use of a wide-array of methods that generate large
amounts of complex data become more common in biomedical research, there is a growing need to develop an
interdisciplinary workforce that can use and further refine computational and statistical approaches to interrogate
this high-content data. Within this phase of dkNET, a new Computational Core has been introduced whose aim
is to bring powerful new AI/ML techniques and cloud computing resources to the NIDDK research community to
fully leverage data assets cataloged by dkNET to explore and develop hypotheses. Here we plan to continue the
dkNET bioinformatics pilot program with a focus on AI to Accelerate Diabetes Research, to capitalize on the
timely opportunity offered by recent AI advances. Specifically, this pilot program will: (1) develop AI foundation
models for T2D; (2) validate the models with top research questions in T2D heterogeneity; (3) disseminate the
models and engage the community for further development, validation and application; and (4) develop use
cases that demonstrate the models’ potential in accelerating the tempo of research.

Public health relevance
PROJECT NARRATIVE As the use of a wide array of methods that generate large amounts of complex data become more common in Diabetes research, the data and prior knowledge about the disease contain critical, but hidden, information relevant to addressing the challenge. The NIDDK Information Network (dkNET) AI to Accelerate Diabetes Research Pilot program will bring new and diverse AI experts into the T2D research workforce, new AI models that other T2D researchers can use, and informative use cases of the new models.